A Pilot Study to Evaluate the Benefits of Phytocannabinoids for the Treatment of Chronic Chemotherapy-Induced Peripheral Neuropathy

Project Summary
Over 15 million cancer survivors live in the US, but unfortunately a large proportion of these patients experience
long-term side effects from their treatments. This includes neuropathy, which is typically characterized by
abnormal symptoms in the extremities including tingling, numbness, pain, or burning. When severe and chronic,
neuropathy can interfere with all aspects of a patient’s life, diminishing their quality of life. Unfortunately for these
patients, no therapy has been successful in helping patients entirely eliminate symptoms. With over 30 states
legally providing medical cannabis, it has become increasing popular among cancer patients. However, the
cancer community has very little data in which to guide patients about its use. By evaluating cannabis’s effect
on neuropathy, we will be able to address this important gap in knowledge.
Two important compounds found in medical cannabis are cannabidiol (CBD) and tetrahydrocannabinol (THC).
This clinical trial will randomize breast and colon cancer survivors with chronic chemotherapy-induced peripheral
neuropathy to two kinds of medical cannabis – CBD versus CBD+THC. Patients will be randomized to CBD,
CBD+THC, or placebo and will be treated for 8 weeks. The results of this research are highly relevant to cancer
survivors as a whole because the findings could be potentially applied to other cancer related pain syndromes.
The data generated from this pilot study will provide important preliminary information needed to properly design
a larger randomized clinical trial to evaluate the efficacy of cannabis for the treatment of CIPN. By helping
patients reduce the symptoms of CIPN, we will help improve their quality of life, their ability to return to work, and
their capacity to maintain an active lifestyle, which has increasingly been shown to help reduce the recurrence
of cancer.

Public health relevance
Project Narrative Chemotherapy-induced peripheral neuropathy is a common side of chemotherapy, and current treatments provide limited benefit for this condition. Early studies of cannabidiol and tetrahydrocannabinol have shown potential improvement in the treatment of neuropathic pain. This randomized placebo-controlled study will provide preliminary data on two types of cannabis for the treatment of chemotherapy-induced peripheral neuropathy, which will inform the design of a larger, randomized controlled trial of medical cannabis.